GURU: Graduate and Undergraduate Researchers of UCEER

PROJECT SUMMARY/ABSTRACT
The phrase “nothing about us without us” has guided disability rights advocates for decades. The basic premise
of the phrase is that conversations about disability, policy decisions affecting people with disabilities, and
technological developments impacting disabled people should include members of the disability community, so
that they can bring their lived experiences with disability to the table. “Nothing about us without us” is
particularly relevant to the domain of genetic science and genetic medicine because it informs a range of
disability-oriented criticisms aimed at those practices. Critics argue that prenatal genetic testing, used in part
to facilitate decisions about bearing children with disabilities, endorses the idea that disability is something to
be avoided rather than accommodated. A genetic policy that recommends testing or screening for certain
conditions but not others is also judged suspect by some disability advocates because the list is an implicit
endorsement of the idea that there are certain traits which make a life not worth living or excessively
burdensome to families and society. Parents making decisions about the result of a genetic test, disability
advocates also warn, are often given poor information about what it is like living with the disability in question.
Attempts to involve people with disabilities in conversations about the ethical, legal, and social implications
(ELSI) of genetic technologies, policies and practices are hindered by the fact that, while students with
disabilities are enrolling in higher education at increasing rates, those students are also dropping out at higher
rates. Long-term mentorship programs are one way to address this retention problem; in particular, programs
that embed students with disabilities into a mentorship network with multiple mentors at the near-peer and
faculty levels, and both with and without disabilities, have proven effective. These programs foster social
integration, self-determination, and a sense of purpose. The goal of this project is to create a program that will
equip undergraduate (2/year) and graduate (2/year) students with disabilities with mentoring, research, and
curricular resources that facilitate their advancement towards becoming members of the professional
community of ELSI scholars. Mentoring resources include a mentor network that incorporates a faculty
research mentor, a mentor with a disability, a near-peer mentor, and an administrative mentor who monitors
their overall progress. Research resources include the opportunity to participate in one or more ELSI research
projects, and then support to present the results of that research at a local research symposium and at national
academic conferences. And curricular resources include enrollment in an interdisciplinary ELSI course, a
course on the responsible conduct of research, and a grant writing workshop (for graduate students) or a
graduate record examination test preparatory course (for undergraduate students).

Public health relevance
PROJECT NARRATIVE The purpose of this R25 Diversity Action Plan grant proposal is to create a program that will equip students with disabilities with mentoring, research, and curricular resources that facilitate their advancement towards becoming members of the ELSI community of scholars. Disability rights advocates argue conversations about disability, policy decisions affecting people with disabilities, and technological developments impacting disabled lives should include members of the disability community; however, this demand—“nothing about us without us”—is hindered by the fact that individuals with disabilities are underrepresented in academia. The proposed program is designed to embrace this demand by creating a future generation of ELSI scholars who have experience living with disability.